Mimics of Enzymes and Antibodies for Glycans and Other Biological Targets

Mimics of Enzymes and Antibodies for Glycans and Other Biological Targets
Project Summary/Abstract
Molecular recognition and catalysis are the foundations for nearly all biological
processes. Scientists have developed strong abilities to inhibit biomolecules at their ligand-
binding or catalytic sites. However, when it comes to complex glycans, long strands of peptides,
or proteins on nonligand-binding sites, it remains difficult to have supramolecular
hosts/materials with biologically competitive binding affinity and specificity. Scientists have long
argued that enzymes are “not different, just better” than synthetic catalysts. Inability to construct
substrate-tailored active sites with precisely installed functional groups, however, has prevented
researchers from accomplishing the catalytic feats of even relatively simple enzymes.
The PI’s group has developed water-soluble, protein-sized, molecularly imprinted
nanoparticles (MINPs) to bind carbohydrates with micromolar affinities and peptides with tens of
nanomolar affinities. In the most recent R01 grant, MINPs have been converted into synthetic
mimics of glycosidase and esterase with enzyme-like specificity and proficiency ((kcat/Km)/kuncat =
109–15 M-1) that operate under physiological conditions. In the next five years, the PI seeks to
develop (a) efficient MINP-based artificial enzymes for selective hydrolysis of glycans, esters,
and amides and (b) MINP–MINP conjugates for complex biomolecules such as glycoproteins
and post-translationally modified proteins. The MINP glycosidase mimics are designed to cleave
sialic acid-containing glycans and the glycosidic bonds in the core 2, 4, 6 of mucin-type O-
glycans that currently lack suitable enzymes for cleavage. The MINP–MINP conjugates will be
used to bind two separate epitopes on a biomolecular target, including glycoproteins and
proteins with posttranslational modifications (PTMs). MINPs have already enabled
applications/collaborations for controlling peptide/protein PTMs, elucidation of T cell signaling,
and targeted degradation of amyloid proteins in neuron cells. All these applications depend
critically on the strong and selective binding of MINPs for their biological targets in water, as well
as their abilities to penetrate cell membranes. As their binding and catalytic properties are
further enhanced, new applications are expect to emerge and new collaborations be made
possible, to help solve important biomedical problems that could benefit from robust,
designable, water-soluble synthetic mimics of antibodies and enzymes.

Public health relevance
Public Health Relevance Statement Molecular recognition and catalysis are the foundations for nearly all biological processes but it is challenging to synthesize supramolecular hosts/materials with biologically competitive binding affinity and specificity. This application builds on recent developments of the PI’s group on the high-fidelity micellar imprinting of biomolecules to develop (a) efficient MINP-based artificial enzymes for selective hydrolysis of glycans, esters, and amides and (b) MINP–MINP conjugates for complex biomolecules such as glycoproteins and post-translationally modified proteins. These materials as robust, designable, water- soluble synthetic mimics of antibodies and enzymes are powerful tools for biomedical research and technology.